PAIN CONTROL IN THE SURGICAL PRETERM NEONATE--BLUNTING THE STRESS RESPONSE

This study measures the stress hormone and metabolic response of neonates following PDA ligation who are randomized to receive postoperative analgesia either as a continuous fentanyl infusion or traditional intermittent boluses.